CTSA UM1 Program at University of California San Diego Altman Clinical and Translational Research Institute

The Altman Clinical and Translational Research Institute (ACTRI) at the University of California San Diego (UCSD) dynamically and rapidly translates scientific discoveries into innovative health solutions. Given the significant growth of our biomedical research portfolio during the last funding cycle, we are positioned to grow our profound impact on advancing translational science and public health within our region and beyond. To amplify our efforts, we will leverage our commitment to scientific collaboration to discover, develop, and catalyze clinical and translational science (CTS) innovations, determine their efficacy and effectiveness, and disseminate and implement these inventions to address challenges in translation. Examples of innovative activities that we are excited about include: An online Business and Finance Platform to streamline hub utilization tracking (Element B), a robust workforce development portfolio that supports CTS researchers across the continuum of their careers, including leadership preparation for early-career investigators with our Leadership Academy (Module C1 and K12); the use of an outreach-driven approach to enhance engagement and expand the reach of our research (Module C2); the use of artificial intelligence in CTS research and a new Next-Gen Trial team to help investigators design and execute decentralized, platform, and adaptive trials (Modules D1, D3); the development of a What’s Next? program to assist early-stage investigators who receive pilot project grants and other ACTRI services in their career planning (Module D2); and new methods for sampling the immune milieu in the upper respiratory tract, use of serious games for developing collaborative science and systems thinking, and finding best ways to provide naloxone to stop overdose deaths in rural San Diego areas (Element E).
To leverage our expertise and avoid over-extending our resources, we have strategically established partnerships. Our biomedical science partners (i.e., Salk Institute, Sanford Burnham Prebys, and La Jolla Institute for Immunology) provide considerable depth in basic science discoveries that require further translation to improve health. Our clinical partners serve in rural areas and regions near the border to improve access to care (i.e., El Centro Regional Medical Center, Eisenhower Health), children and adolescents (i.e., Rady Children’s Hospital), and military veterans (i.e., Veterans Affairs San Diego Healthcare System). Our new higher education partner, Mesa College of the San Diego Community College District, has a superb track record of advancing student success through well-supported programs and services. Through these strategic alliances and a focus on collaborative innovation, the ACTRI is not just advancing CTS, it is delivering measurable impact, and building a highly-skilled, sustainable workforce that will drive groundbreaking health solutions to address evolving health priorities.

Public health relevance
The Altman Clinical and Translational Research Institute (ACTRI), the home of our Clinical and Translational Science Award (CTSA) hub, has strategically partnered with leading local biomedical, clinical, and educational institutions to advance clinical and translational science (CTS) as a new discipline, driven by innovation, integration, and collaboration. The ACTRI also aims to develop a highly skilled CTS workforce that accelerates the translation of research into groundbreaking health solutions. The ACTRI strategically provides resources and infrastructure to support the development, implementation, and widespread dissemination of CTS solutions, improving health outcomes and supporting delivery of high-quality care across our region and beyond.